Molecular dissection of Hematopoietic Stem Cell specification triggered by inflammatory mediators

Project Summary
Due to the unique property of hematopoietic stem cells (HSCs) to reconstitute the entire blood system of
the organism, these stem cells are utilized clinically to treat blood disorders. The possibility of culturing and
expanding HSCs in vitro would make hematopoietic stem cell transplantation (HSCT)-based therapies more
feasible. However, this has eluded the field for more than three decades, necessitating a closer examination of
the native developmental mechanisms that govern the emergence of HSCs. Many years of investigation have
revealed that HSCs require multiple molecular inputs for proper specification, including activity of the Notch, nitric
oxide (NO), Wnt, FGF, and BMP signaling pathways. In addition, inflammatory signaling (Tnfa, NF-kB, Tlr4,
interferons, Il1b and inflammasome) have been recently reported as a novel group of HSC fate modulators, yet
the underlying molecular mechanisms are unclear. Addressing this knowledge gap will be critical to help develop
in vitro protocols for the generation of patient-specific HSCs. The goal of this proposal is to reveal in vivo the
inflammatory network that unlocks HSC specification from the hemogenic endothelium (HE), and its relationship
with the Notch and nitric oxide pathways. To attain this goal, the following three specific aims will be pursued:
(1) Identify the role of Nod1 signaling during HSC development; (2) determine the mechanism of NF-kB-directed
HSC specification; and (3) analyze the impact of the NOD1/RIPK2/NF-kB inflammatory axis on human
pluripotent stem cell-derived definitive hematopoietic progenitor cells.
Since hematopoietic development is highly conserved between vertebrate species, the zebrafish model
provides a unique opportunity to circumvent the challenges of in utero experimentation, permitting non-invasive
experiments that avoid the artifactual inflammation caused by cellular stress. To achieve this application's goals,
a combination of novel zebrafish reporter and mutant lines, new methods to perform epigenomic and
transcriptomic profiling of the HE by CUT&RUN-sequencing and RNA-sequencing, live imaging of HSC
development by confocal and light-sheet microscopy, qPCR, FACS-sorting, and lineage tracing using Cre-
mediated reporter systems will be utilized. In addition, to translate these in vivo findings to human health, this
proposal will be complemented with a model of hematopoietic differentiation from human pluripotent stem cells
(hPSCs). Upon successful completion of the proposed research, a previously undescribed inflammatory pathway
affecting HSC specification will be identified, in addition to the central molecular mechanism by which
inflammatory signaling drives HSC fate and crosstalk to other main HSC inductors. These new findings could
provide key insights needed to instruct HSC fate, informing in vitro approaches to generate HSCs from pluripotent
precursors for the treatment of blood disorders.

Public health relevance
Project Narrative This research will contribute to fundamental knowledge of the molecular mechanisms required to specify hematopoietic stem cells. The proposed research is relevant to public health because these findings will inform the development of in vitro protocols for the generation of patient-derived hematopoietic stem cells to treat blood disorders such as leukemia, anemia and hemoglobinopathies, enhancing these patient's treatment options and success rates.